Country-Specific Modeling of Verbal Autopsy Misclassification for Improved Child and Neonatal Cause-Specific Mortality Estimates at Low- and High-Resolution Causes

The primary objective of this K99/R00 application is to develop Dr. Sandipan Pramanik’s (PI) research skills to
improve our understanding of disease burden among children under age 5 in low and middle-income countries
(LMICs). The K99 phase of the proposed research will support PI in accomplishing four training objectives.
This will enable his seamless transition into an independent global health investigator, enhancing mortality
surveillance through impactful solutions that integrate multi-source data. First, he will broaden his
understanding of factors impacting child and neonatal mortality in LMICs, along with foundational statistical and
demographic surveillance methods. Second, by conducting field visits, he will gain firsthand experience and
insights into on-site data collection, method/software implementation, and associated challenges. He will also
arrange direct studies to acquire knowledge on different causes of death (CODs) diagnoses (such MITS,
verbal autopsy (VA)), and their medical background. Third, by visiting collaborators, he will enhance his
expertise through research presentations and discussing competing/complementary methods. Fourth, he will
seek professional development opportunities, emphasizing grant writing and collaboration. Based on the
training objectives and utilizing unique access to essential rich data sources (CHAMPS, COMSA), this
proposal is timely and pivotal for enhancing mortality estimates, focusing on children under age 5. With the
acquired skills from training, the PI will be well-positioned to successfully achieve the three research aims,
expanding VA-calibration applicability. Utilizing paired MITS-VA COD data and tackling systematic bias and
heterogeneity, Aim 1 will develop a concise country-specific VA misclassification modeling framework,
enhancing mortality estimation covering detailed causes. In a first, Aim 2 will design efficient Bayesian tests to
effectively compare hypotheses about different effects in VA misclassification. In contrast to classical tests, this
will facilitate more efficient and clear statistical decision-making. Using national-level estimates, Aim 3 will
create a novel statistical downscaling framework. This will enhance inference for sub-populations at the sub-
national level, including age groups, sexes, and geographic regions, ensuring coherence with population-level
estimates. Complementing Aims 1–2, it will also distribute open-source software and apply proposal outputs to
various projects and grants, with immediately improved mortality estimates in Mozambique and Sierra Leone.
This proposal will accelerate the worldwide effort to improve child mortality surveillance. It also aligns with the
US government and international community’s objective to assess the effectiveness of age and disease-
specific interventions, such as malaria vaccine2 or azithromycin3, in combatting the primary causes of mortality
among them. The collaborative efforts between the Departments of Biostatistics and International Health at
Johns Hopkins, involved in initiatives like COMSA in Mozambique and CHAMPS, offer an ideal environment to
receive the research support and resources to attain his training and research objectives.

Public health relevance
Leveraging the unique access to data collected by CHAMPS, the proposal seeks to improve our understanding of the underlying causes of sudden infant death syndrome and unexpected deaths in children. Accommodating detailed causes, it will develop state-of-the-art statistical frameworks and software for estimating the misclassification of verbal autopsy (VA) algorithms, which will lead to more valid (accurate and precise) age- and cause-specific mortality estimates for children under age 5 in low- and middle-income countries. Given VA’s ubiquitous influence in strengthening civil registration and vital statistics systems, this proposal valuably complements the effort, enabling the derivation of more valid cause-specific mortality estimates for any country, regardless of the availability of high-fidelity (such as MITS) cause-of-death data.